Identifying Mechanisms of Tfh/Germinal Center B cell Pathogenicity in Type 1 Diabetes

PROJECT SUMMARY
In Type 1 Diabetes (T1D), B lymphocytes present islet autoantigens to T cells, driving autoimmune destruction
of pancreatic beta cells. Clinical trials targeting these T cell-B cell interactions have shown relative success,
highlighting the importance of understanding pathogenic T-B interactions more precisely. The immediate
challenges of these immunotherapies include a delay of T1D rather than durable protection, heterogeneity in
individual responses, and undesirably broad immunosuppression. A major gap in knowledge of T1D
pathogenesis is how T cells interact with B lymphocytes to expand and acquire pathologic functional potential.
T follicular helper (Tfh)-like populations are increased in the peripheral blood of T1D individuals and high-
affinity islet autoantibodies predict disease, pointing to a key role for germinal center (GC) Tfh cell/GC B cell
responses in T1D. In non-obese diabetic (NOD) mice, Tfh cells can transfer diabetes. Work from our lab and
others show that anti-insulin B cells can spontaneously adopt a GC phenotype, and that they can drive anti-
insulin T cells to differentiate into Tfh cells. Conversely, pathogenic anti-insulin T cell clones drive anti-insulin B
cells to become GC B cells and produce insulin autoantibodies. Our recently published work demonstrated that
CD4-driven expression of Bcl6, which controls GC B cell and GC Tfh differentiation, is required for T1D.
Therefore, I hypothesize that T1D anti-insulin B cells depend on interactions with GC Tfh cells to license the
proinflammatory subsets of T cells that drives T1D pathogenesis. To test this hypothesis, we developed several
new NOD models that allow dissection of the Tfh/GC B cell axis. These include 1) a model in which genetic
deletion of SLAM-associated Protein (SAP) enables contrast between benign (SAP-/-) vs. pathogenic (SAP+)
Tfh cells, 2) Bcl6fl/fl models, and 3) anti-insulin BCR and TCR transgenic mice with which we can separate
autoreactive B and T cell expansion from their acquisition of effector functions, and how this process is
impacted by loss of the key GC proteins, BCL6 and SAP. In Aim 1, I will determine the need for anti-insulin B
cell engagement with Tfh cells in supporting lymphocytic invasion of islets and diabetes development. In Aim
2, I will dissect the pathogenic vs. benign Tfh phenotypic, metabolic, and transcriptomic changes in driving T
cell functional changes in T1D. In Aim 3, I will characterize known and novel subsets of circulating Tfh-like
cells elevated in PBMCs isolated from pre-symptomatic T1D individuals as they progress to diabetes onset.
These experiments will identify key features of pathogenic Tfh cells in both mouse and human cells and will
provide insight into the molecular control of pathogenic T/B lymphocyte interactions. Studies using mouse
models will link pathogenic immune infiltration of beta cells with changes that are observable in the peripheral
blood, as this is a practical biospecimen for clinical evaluation of progression in pre-symptomatic T1D
individuals, and immunotherapy response. This work thus holds potential to uncover novel immunologic
biomarkers and immunotherapeutic targets to delay or prevent beta cell destruction in T1D.

Public health relevance
PROJECT NARRATIVE The emergence of immunotherapies for Type 1 Diabetes (T1D) has begun, yet there remains a critical need to understand how autoreactive B lymphocytes drive T cells to attack beta cells. T follicular helper cells (Tfh) cells are elevated in recent onset T1D populations, but the mechanisms of how they interact with B lymphocytes to drive T1D pathogenesis are unclear. This proposal will use unique mouse models, human samples, and novel approaches to determine how Tfh cells become pathogenic via anti-insulin B cell interactions in the germinal center response.